Reactivation of Chronic Toxoplasmosis

Project Summary/Abstract
Toxoplasma gondii is a widespread parasite of animals that cycles between cats, which shed infectious
oocysts in their feces, and a variety of animals that harbor long-lived chronic infections. Humans are also
commonly infected either by ingestion of oocysts in contaminated water, or by ingestion of tissue cysts in
undercooked meat. Following infection, the parasite initially proliferates as fast-growing tachyzoites, which
disseminate widely in the body. It then differentiates into semi-dormant bradyzoites that reside within tissue
cysts, most commonly in muscle and brain. Although infections in healthy individuals are controlled by the
immune system, tissue cysts persist in the face of immunity and are not eliminated by drug treatment. As such,
chronic infections with T gondii pose a serious risk to HIV-infected AIDS patients due release of parasites from
semi-dormant tissue cysts and re-emergence of the highly proliferative tachyzoite stage, which can lead to life
threatening complications.
Although once considered latent, newer studies reveal that bradyzoites replicate, albeit asynchronously
and infrequently. Moreover, tissue cysts periodically rupture to release bradyzoites that infect new host cells
and give rise to daughter tissue cysts. One barrier to egress of bradyzoites is their rigid cyst wall, comprised of
proteins and carbohydrates, including the dominant antigen CST1, which is heavily glycosylated by O-linked
sugars. Loss of CST1, or deletion of its mucin domain, results in fragile cysts, implying that this glycoprotein
provides rigidity to the cell wall. Consistent with the idea that carbohydrates form a critical part of the cyst wall,
our studies demonstrate that exogenously added glucanase and chitinase enzymes digest the cyst wall and
result in release of bradyzoites. To explore endogenous pathways that control this process, we will examine
the roles of two parasite glycosyl hydrolases that are expressed in bradyzoites, secreted from the parasite, and
localized to the cyst wall. Genetic disruption of glucanase (GLN1) and chitinase-like protein (CLP1) genes in a
cystogenic strain of T. gondii results in reduced formation of daughter cysts, supporting the hypothesis that
these enzymes contribute to cyst maturation and turnover. We will examine the substrate specificity of these
enzymes in vitro and assess their roles in vivo in formation and turnover of tissue cysts. We will also examine
the role of these glycosyl hydrolases in chronic infection of immunocompromised mouse models that closely
mimic impaired immunity seen in HIV-infected AIDS patients. The proposed studies will explore the hypothesis
that glycosyl hydrolase enzymes contribute to the turnover of tissue cysts resulting in reactivation of
toxoplasmosis, which poses a major risk for severe disease in HIV-infected AIDS patients.

Public health relevance
Narrative Toxoplasma gondii is a common infection of humans and it frequently causes chronic infections that pose risk for those with HIV infection due to decreased immunity. Chronic infections are characterized by tissue cysts containing the parasite that form in organs including the brain. The proposed studies are important for defining the mechanism of tissue cyst turnover that results in reactivation of chronic infection and causes serious disease in HIV-infected AIDS patients.